Functional Heterogeneity of Hypocretin Neurons

Functional heterogeneity of Hcrt neurons
Complex neuronal circuits regulate arousal, and deficiencies in these circuits are a highly prevalent
cause for sleep disturbances and anxiety disorders. The multi-functional hypocretin/orexin (Hcrt)
neurons regulate arousal-related behavioral states including sleep, wakefulness, feeding,
emotions, stress and reward. However, how a presumably uniform Hcrt population regulates such
diverse functions, and how alteration in these circuitries result in sleep and anxiety disorders is
not clear. We hypothesize that Hcrt neurons are genetically, anatomically and functionally
heterogenous, and that subpopulations of Hcrt neurons projecting to different brain regions
regulate specific features of sleep and arousal. Here, we will use a combination of viral
monosynaptic circuit tracing, two-photon live imaging of single synapse and neuronal activity,
optogenetics, fiber photometry and behavioral experiments in zebrafish and mice to identify and
elucidate the function of subpopulations of Hcrt neurons in regulating sleep. In aim 1, we will use
retrogradely transported viral vectors and live imaging of single pre- and post-synaptic structure
to characterize anatomically distinct subpopulations of Hcrt neurons, innervating the VTA, LC and
TMN regions. The transparent zebrafish model enables anatomical and functional live
visualization of the relatively simple, but conserved, Hcrt system (20-40 cells). In aim 2, fiber
photometry recording in behaving mice and real-time two-photon imaging of neuronal activity in
single cell resolution will be performed to elucidate the differential neuronal activity of
subpopulations of Hcrt neurons in regulating sleep and arousal. In aim 3, optogenetic, synaptic
silencing and genetically induced neuron ablation will be used to manipulate subpopulations of
Hcrt neurons. We will monitor the effect on neuronal activity in post synaptic dopaminergic and
histaminergic target neurons using genetically encoded calcium indicators. These neuronal
activity recordings will be complemented with behavioral experiments in mice. The results are
expected to challenge the generalized assumption that neurons that secrete a specific
neuropeptide share similar identities and functions. The combined strength of the two vertebrate
models will uncover the role of evolutionary conserved sub neuronal circuitries and may provide
new therapeutic targets for the treatment of sleep disorders.

Public health relevance
Among the billions of neurons in the brain, a group of a few thousand neurons producing a hormone called hypocretin or orexin stand out as one of the most prominent in the control of sleep and wakefulness. Here we will use a collection of state of the art methods to characterize subsets of hypocretin neurons and how they respond to different stimuli in both mice and zebrafish. Our studies will have profound implications in our interpretation of the mechanisms underlying sleep control and may lead to better treatments for neuropsychiatric disorders associated with dysfunction of arousal neuronal systems.